Pediatric Ambulatory Blood Pressure Trajectory and Brain Health in Midlife

ABSTRACT
Loss of cognitive function is one of the most feared and devastating manifestations of aging and vascular disease.
Although decades of research have identified multiple risk factors for cognitive decline and dementia, it remains
unclear when in the lifespan, and for whom, prevention and intervention programs should be
implemented. It has been suggested that impaired cognition could be a clinically silent disorder starting in midlife
or even earlier, and may have a root extending back into early life. This is particularly relevant to hypertension,
not only because hypertension has been recognized as an important modifiable risk factor for dementia and
cognitive impairment, but also the prevalence of elevated blood pressure (BP) among pediatrics has been
increasing worldwide. However, currently there is not enough evidence linking early life BP to midlife brain
function to warrant examining treatment effects in hypertensive children on cognition or markers of brain health.
The goal of this project is to disentangle the long-term impact of elevated BP in early life on brain
structure and cognitive function in midlife. This will be achieved by utilizing the Georgia Stress and Heart
study of over 600 children (49% black and 50% females) who were measured up to 16 times in 23 years. We
have collected comprehensive data from childhood to adulthood, including 24-hour ambulatory BP (ABP),
chronic stress and behaviors, as well as measures of atherosclerosis and arterial stiffness. In this project, we
will conduct an additional follow-up of these subjects using magnetic resonance imaging (MRI) (including arterial
spin labeling (ASL) perfusion and brain diffusion tensor imaging (DTI)), and neurocognitive testing. The specific
aims are: Aim1: To examine (a) whether elevated BP levels and/or greater BP increases over time in early life
are associated with altered cerebral perfusion and brain structure, and impaired cognitive function in midlife, and
(b) at what age this impact starts to occur (e.g. childhood or young adulthood). Aim2: To examine whether
progression of arterial stiffness and atherosclerosis (assessed by pulse wave velocity and carotid intima-media
thickness measured in multiple visits) in early life (a) contributes to brain functional and structural deviation, and
cognitive impairment in midlife, and (b) at least partially mediates the impact of elevated BP in early life on
impaired brain and cognitive health. Aim3: To examine whether chronic stress and/or related unfavorable
behaviors interact with elevated BP, and accentuate the adverse impacts on vascular, brain and cognitive health.
The secondary aim is to explore whether these relationships are moderated by ethnicity and gender.

Public health relevance
This project will lay the groundwork for examining the impact of elevated BP during early life on brain and cognitive health in midlife. It will aid in the identification of key factors, timing and subpopulation to target for developing novel prevention and intervention strategies at an early stage that could slow the progression of aging process in vasculature and brain, eventually averting accelerated cognitive decline in late life.